ShEEP Request for MagVenture rTMS machine with EEG and fMRI synchronization

Project Summary / Abstract
For this Office of Research Development Shared Equipment Evaluation Program (ShEEP) proposal,
we are requesting a Transcranial Magnetic Stimulation (TMS) device with functional magnetic
stimulation (fMRI) and electroencephalogram (EEG) integration as a shared-equipment resource to
be used primarily for mental health research on posttraumatic stress disorder (PTSD), traumatic brain
injury (TBI), depression, schizophrenia, and chronic pain. The requested TMS device is state-of-the-
art and capable of delivering brief pulses of high alternating magnetic fields. TMS is an essential tool
for cognitive/translational neuroscientific investigations and also used to induce long-term plasticity
and improve outcomes in clinical interventions. TMS is currently FDA approved to treat major
depression and obsessive-compulsive disorder, and there are many clinical trials ongoing for multiple
other conditions.
At the Jennifer Moreno VA Medical Center (JMVAMC), there are several TMS devices, but all are
dedicated primarily for clinical services and almost entirely occupied at present. Moreover, these
devices are optimized for the FDA-approved treatments and do not have all of the capabilities
typically required for research-based investigations. The advanced features of the device we are
requesting include fMRI and EEG compatibility and the ability to perform high-frequency (i.e., theta-
burst-stimulation) high-power pulses. This device also comes with the full assortment of accessories
(coil, seating chair, coil holder, and the full assortment of MRI-safe equipment) required to perform
the studies outlined in the Research Plan.
With this device, there are a number of current and future research projects that would be facilitated,
including basic cognitive neuroscience investigations into neural mechanisms underlying PTSD and
TBI and clinical/translational research in several mental health disorders, including PTSD, TBI,
depression, schizophrenia and chronic pain. This device has the potential to accelerate clinical
research at JMVAMC across a wide-variety of PIs and research projects focused on mental health
and related conditions.

Public health relevance
This proposal is to acquire a new fMRI and EEG-compatible TMS device dedicated for mental health clinical/translational research. The acquisition of this device will enable and catalyze many investigations at JMVAMC into using this tool to help delineate and ameliorate cognitive and emotional problems in a range of psychiatric conditions prevalent in Veterans, including PTSD, TBI, depression, schizophrenia and chronic pain.